Lipoxygenase Signaling in Heart Failure Pathology

Summary: Chronic inflammation following myocardial infarction (MI) can progress to heart failure (HF) with
excess morbidity and mortality; therefore, improvement in left ventricular (LV) function and survival after MI are
hard endpoints that provide the ultimate test of therapeutic efficacy. While multiple factors impact adverse
cardiac remodeling and HF progression, emerging studies lend credence to the concept that aberrant lipid
metabolism contributes importantly to chronic inflammation and subsequent HF. Traditionally, all lipoxygenase
(LOX)-derived lipid mediators have been considered
proinflammatory and detrimental. However, acute
inflammation is necessary for early healing; therefore, rather than inhibition of all inflammation,
the goal of
therapy should be to achieve an optimal balance between inflammation-promoting and -resolving factors. Our
data indicate that deletion of 12/15LOX in mice delays HF post-MI, improves infarct healing, and reduces LV
dysfunction and mortality
by promoting the formation of the resolving lipid mediators, cypoxins that polarize
leukocytes to a reparative phenotype.
These data suggest that 12/15LOX activity underlies non-resolving
inflammation following MI, thereby negatively impacting LV function and mortality. Our data in mice and
patients with HF suggest that an eicosanoid product of 12/15LOX-induced arachidonic acid metabolism, 12(S)-
hydroxyeicosatetraenoic acid, delays leukocyte clearance in the post-MI heart, delaying inflammation
resolution. Which specific myeloid-leukocyte population contributes to bioactive lipid mediator generation after
MI remains unclear; our data point to a critical role for macrophages. Thus, we hypothesize that macrophage-
produced 12/15LOX is a key regulator of both inflammation-triggering and -resolving pathway(s) after MI
healing, and these must be balanced to alleviate the progression to HF. To test this hypothesis, we propose
three aims. Aim 1: Determine if 12/15LOX deficiency reduces inflammatory mediators to control overactive
inflammation in acute HF after MI (days 1 to 5), using a myeloid-specific 12/15LOX-knockout mice. Aim 2: Test
whether myeloid-specific 12/15LOX deficiency limits proinflammatory and promotes proresolving mediators
biosynthesis to promote effective healing after MI, and thereby delays the progression to chronic HF.
We will
determine the proinflammatory and proresolving mediators in the infarcted area using quantitative and imaging
mass spectrometry approaches that were
technologically unfeasible before, and determine the mechanism by
which macrophage-specific 12/15LOX balances proinflammatory and proresolving mediators. Aim 3: Establish
whether post-MI inhibition of 12/15LOX augments the biosynthesis of proresolving lipids acutely and
chronically after MI, and thereby facilitates LV healing and repair. Collectively, the proposed studies will define
the role of 12/15LOX in the
initiation, resolution, and progression
of inflammation post-MI. To accomplish this,
we have enlisted inflammation, HF, and biostatistics experts to complement our expertise in lipid signaling. The
new knowledge gained will advance the development of novel therapeutic targets/drugs to ameliorate HF.

Public health relevance
Heart failure is the leading cause of death after a heart attack. Chronic and unresolved inflammation is the hallmark of advanced heart failure and is attributed to multiple factors, including aberrant lipid metabolism and leukocyte function and changes in heart geometry and function. The ultimate goal is to identify cellular and molecular mechanisms of non-resolving inflammation that may be targeted to attenuate heart dysfunction and failure following a heart attack.